Objective lung assessment tools for improved organ use in lung transplantation

Project Summary/Abstract
Primary graft dysfunction (PGD) is the most common cause of morbidity and mortality after lung
transplantation resulting in significant negative effects on quality of life and cost. PGD has a
complex relationship with donor organ use because uncertainty in organ quality and concern
that poor donor quality causes susceptibility to PGD results in high discard rates for potentially
transplantable organs. With almost 1 in 5 candidates dying awaiting lungs for transplant, calls
for new methods to define donor quality and PGD risk have become a major public health
challenge.
The long-term objective of our line of research is to prevent recipient death and expand the
donor pool through better donor selection. Recent evidence suggests innate immune activation
is important in PGD pathogenesis based on transcripts from donor lung tissue, bronchial wash
and blood. Using these transcripts, we have developed two objective gene expression based
risk assessment tools to stratify PGD risk and identify organs which may be suitable for
transplant from the pool of unused organs. Utilizing these tools, we will conduct a prospective
multicenter cohort study to externally validate our prediction tools for donor pool expansion.
Successful completion of our aims will lead to an objective marker of donor organ quality whose
application will simplify subjective decision making in donor selection and identification of new
organs for donor pool expansion.

Public health relevance
Project Narrative PGD occurs in almost a third of lung transplant recipients, is the most common cause of death in the perioperative period and has a major impact on morbidity, quality of life and cost. Uncertainty in organ quality and concern that poor donor quality causes susceptibility to PGD results in high discard rates for potentially transplantable organs. The long-term objective of this line of research is to develop objective tools to stratify PGD risk so more organs will be used for transplant and high-risk organs can be identified early for advanced therapies.